Human Pancreas Analysis Program for Type 1 Diabetes - HPAP-T1D

Human Pancreas Analysis Program for Type 1 Diabetes (HPAP-T1D)
Abstract
Building on the extensive existing infrastructure and scientific collaborations within the Human Pancreas
Analysis Program for T1D (2017 – present), we will continue and expand the work and technology of our
six cores to advance research in human type 1 diabetes (T1D). Core A will procure human pancreata,
immune tissues, and detailed donor medical histories from T1D, non-diabetic but autoantibody-positive
(AAb), and control donors; collect immune tissues and isolate islets; and distribute high-quality islets,
tissues and cells to the other Cores for further analysis or processing. Core B will perform rigorous
physiological phenotyping by perifusion and oxygen consumption assays on the isolated islets, and single
islet measurements of intracellular calcium, as well as implement newer technologies to study cell
composition. Core C will perform sophisticated immune profiling in spleen and lymph nodes by cell type
mapping with differential gene expression and chromatin accessibility analysis, generation of a memory B
cell and T cell clonal atlas across different tissues, and specificity analysis on circulating antibodies and
selected T and B cell receptors. Core D will perform multiple advanced modalities for the molecular profiling
of isolated islets including RNA-seq and DNA methylome analysis of sorted islet cell populations; single
cell ATAC-seq and RNA-seq, flow mass cytometry for single cell quantification of more than 30 cell surface
and intracellular markers, and spatial transcriptomics. Core E will process all tissues using multiple fixation
modalities, cmduct pathology analysis, and biobank remaining pancreatic tissues. Core E will also perform
advanced tissue morphometry, including highly multiplexed immunofluorescent imaging using CODEX.
Finally, Core F will assemble, annotate, maintain and upgrade an extensive open-access database
(PANC-DB) for the program and its member-researchers, and collaborate with HIRN in the sharing of data.
The entire program is directed by an Executive Committee consisting of the core leaders and the contact
PI, who will interface with HIRN and NIDDK leadership. Taken together, HPAP-T1D will provide
physiologic, genomic, genetic, immunologic and histologic analyses of the pancreas and immune-
associated tissues in T1D and share these comprehensive, integrative and robustly quality controlled data
with researchers world-wide.

Public health relevance
The Human Pancreas Analysis Program for Type 1 Diabetes (HPAP-T1D) Narrative Recent decades have witnessed a dramatic improvement in our ability to study human tissues relevant to the etiology of type 1 diabetes. Using state-of-the-art technologies, we are profiling the genetic, metabolic, immunologic, spatial and functional properties of cells in the disease-relevant tissues of organ donors with type 1 diabetes and pre-diabetes. This comprehensive profiling is providing new insights into the mechanism of diabetes and will lead to new treatment modalities for preventing or curing the disease.